hiPS cells derived skeletal muscle progenitors and their extracellular vesicles for treatment of sarcopenia

PROJECT SUMMARY
Aging of skeletal muscle results in sarcopenia. It is believed that sarcopenia is in part due to a decreased capacity
of stem cells, namely satellite cells, to repair the skeletal muscle after injury. Satellite cells are the major source
of myogenic progenitors for adult muscle homeostasis and repair. A potential alternative for dysfunctional
satellite cells is induced pluripotent stem cells (iPSC) which have the capacity to differentiate into skeletal muscle
myocytes and blood vessels. Here, we have identified a highly efficient small molecule, givinostat (Givi), a histone
deacetylase inhibitor (HDACi) which is capable of transforming human iPSC into myogenic progenitor cells (MPC)
that are highly proliferative and generate large numbers of extracellular vesicles (EV). Our “pharmacological
reprogramming” approach using small molecules to generate MPC in a limited period of time and without use of
viral vectors is a very significant step forward in cell-based therapy. We are proposing that iPSC
pharmacologically reprogrammed into MPC with Givi will be optimally effective to regenerate sarcopenic muscle.
In specific aim 1, the hypothesis that induced myogenic progenitor cells (iMPC) from iPSC with novel small
molecules are effective and safe for regeneration of aged muscle will be tested; In specific Aim 2, the hypothesis
that accelerated mobilization and engraftment of iMPC in an aged muscle microenvironment stimulate muscle
regeneration will be tested; In specific Aim 3, the hypothesis that EV derived from Givi-induced MPC rejuvenate
aged muscle and augment muscle regeneration will be tested. If many of the regenerative properties of iMPC
can be credited to EV, there will be a paradigm shift in regenerative medicine to enable endogenous self-repair
in sarcopenia by cell to cell transfer of proteins, mRNAs, and miRNAs (miRs) by EV. EV from engineered or
modified stem cells are highly enriched with bioactive molecules including myogenic miRs responsible for
activation of signaling pathways important in muscle regeneration. These studies will involve multidisciplinary
approaches which will employ state of the art molecular biology, biochemical, histochemical,
immunohistochemical techniques and integrative physiology involving well established experimental animal
model and muscle function. This proposal is conceptually innovative because it addresses the structural and
molecular characterization of iMPC and their EV and tests their role as key biological messengers of iMPC action
in the treatment of sarcopenia.

Public health relevance
PROJECT NARRATIVE The ability of the resident muscle stem cells to maintain and repair skeletal muscle declines progressively in the elderly and severely affect muscle strength, mobility and quality of life. The current application will develop novel strategies using induced pluripotent stem cell derived muscle progenitors and their extracellular vesicles to reverse the senescence process of muscle stem cells and to enhance the therapeutic efficacy of stem cells for the treatment of sarcopenia.